Development of Lipid Nanoparticles for Effective Endosomal Escape

Development of Lipid Nanoparticles for Effective Endosomal Escape
PROJECT SUMMARY
Nucleic acid-lipid nanoparticles (NA-LNPs) are internalized by cells primarily through endocytosis. Upon
binding to the cell surface, the plasma membrane invaginates to trap the LNPs within a cellular vesicle known
as the endosomes. Research indicates that only 2–4% of nucleic acid cargo escapes the endosome during NA-
LNP treatment, underscoring the necessity of enhancing cytoplasmic release to fully utilize LNPs’ potential.
Another significant challenge is the reactogenicity of LNPs, which refers to the inflammatory response triggered
by vaccination. While vectors can enhance the host’s antigen-specific immune response and reduce dosage
requirements, they often increase reactogenicity. This suggests that these components, independent of nucleic
acid cargo, possess structural components that induce such responses. Even FDA-approved LNP vectors, like
BNT162b2, exhibit reactogenicity, as evidenced by phase 2/3 trial safety results. Therefore, addressing both
these issues, including optimizing both endosomal escape and reactogenicity, is crucial for balancing efficacy of
NA-LNP therapy with acceptable levels of pain and potential risks.
Ionizable lipids (ILs) play a pivotal role in determining both the efficiency of LNP endosomal escape and
reactogenicity. Herein, we propose three universal strategies: (a) enhancing electrostatic interactions between
LNPs and endosomal membranes using pH-switchable pyridine carboxybetaine ILs; (b) integrating lipophobicity
into LNPs through fluorinated zwitterionic ILs; and (c) improving hydrophobic interactions between LNPs and
membranes by utilizing virus protein-mimicking ILs. Over the past 20 years, the PI has demonstrated the
excellent biocompatibility of zwitterionic materials in various biomedical applications. Incorporating zwitterionic
groups into the chemical design of ILs offers a promising approach to reduce reactogenicity. For each approach,
we will synthesize unique lipid headgroups to establish the desired properties and understand their structure-
property relationships. Once these criteria are met, we will attach the most effective headgroups to a library of
lipid tails. LNPs will then be formulated, optimized, and subjected to thorough physical characterization to assess
how the structure-property relationships of small molecule headgroups translate to the final LNP performance.
This research aims to uncover new and universal structure-function relationships to guide the design of unique
lipids with innovative chemical structures, ultimately enhancing the technology of nucleic acid therapeutics,
particularly for mRNA therapy. The successful execution of this work will address the critical knowledge gaps
needed to advance this field.

Public health relevance
PROJECT NARRATIVE This project aims to develop a series of zwitterionic ionizable lipids (ILs) that can interact strongly with endosomal membranes for constructing efficient and safe LNP-based nucleic acid (NA) delivery systems. We seek to leverage these novel approaches to uncover new structure-function relationships, design unique lipids with novel chemical structures and advance the technology of NA therapeutics for a broad range of applications.